Phase 0/1b Clinical Trial of Novel Therapeutic Agent MT-110 for the Reduction of Methamphetamine Use - Part 2

PROJECT SUMMARY
As of 2023, close to 2 million individuals in the United States are identified as having
methamphetamine use disorder (MUD), with methamphetamine use rising significantly. Recent
estimates suggest that this figure is underreported by about 225%, bringing the 2023 total closer
to over 4 million people with MUD, and likely even higher in 2024. MUD is a persistent condition
for which there are no FDA-approved medications at present. The current treatments available
are behavioral modification therapies, which show limited success, as indicated by high relapse
rates (60-90%). This underscores the need for an additional pharmacotherapy that targets relapse
triggers to help maintain abstinence. Comprehensive prior studies by our group and others have
shown that relapse induced by drug-use reminders (or “triggers”) exerts a strong motivational
influence, posing a lifelong relapse risk regardless of the duration of abstinence. Myosin
Therapeutics is developing MT-110, a drug marked by the novel therapeutic target of the
molecular motor nonmuscle myosin II (NMII). Preclinical research has demonstrated that a single
acute inhibition of NMII activity can produce a highly specific, long-lasting effect by restoring the
brain’s structural plasticity to a pre-methamphetamine state. Consequently, a single intravenous
dose of MT-110 results in a lasting reduction in methamphetamine-seeking behavior in animal
models. IND-enabling studies for MT-110 are complete, and Phase 1b clinical trials are set to
commence in the first quarter of 2025. MT-110 is being developed as a one-time administration
medication to support the reduction of MUD. The primary goal of this Direct to Phase II SBIR
application is to support a first-in-human double-blind, placebo-controlled single ascending dose
(SAD) Phase Ib dose escalation trial of MT-110 in individuals that consume METH. This proposed
1b trial of MT-110 will recruit up to 44 patients to test 5 dose levels and determine CNS drug
concentrations via CSF collection in an additional cohort following administration of an optimal
dose. The primary endpoints are focused on determining the safety and tolerability of single
ascending doses of MT-110. Secondary endpoints will gather pharmacokinetic parameters, both
systemic and CNS. And an exploratory endpoint will assess potential changes from baseline in
the craving for METH. In this application (current application – ‘Part 2’), we detail the specific
activities that will be performed by the clinical research unit (CRU) to complement the activities
that the Sponsor (Myosin Therapeutics) will perform with support from a CRO (detailed in sister
application – ‘Part 1’). The Part 2 activities detailed here cover interaction with patients to execute
the trial.

Public health relevance
PROJECT NARRATIVE Rates of methamphetamine (METH) use and accidental overdose deaths are surging and there are currently no medications for treatment, leaving only abstinence support and various behavioral modification therapy modalities. Myosin Therapeutics is developing a first-in-class nonmuscle myosin II (NMII) small molecule inhibitor, MT-110, where preclinical studies indicate that single administration produces a long-lasting, potentially permanent, disruption of the motivation to seek METH. This application will support execution of a first-in-human Phase I clinical trial to determine safety, tolerability and systemic and central pharmacokinetics of MT-110.